Predicting Late Talkers in Infants who are at Elevated Familial Likelihood for Autism

ABSTRACT
Predicting Late Talkers in Infants who are at Elevated Familial Likelihood for Autism
Autistic children are late to say their first word, and these early challenges persist with over 70% of autistic
preschoolers having language impairment. Siblings of autistic children unaffected by autism themselves are at
a 4-5-fold increased risk of developing language challenges. The field lacks screening tools with strong
predictive power to identify late talking autistic children during the birth-to-three early intervention period. The
proposed project makes significant steps towards early identification of language impairment and understanding
the developmental sequelae of language in autistic toddlers by leveraging data from the Baby Sibling Research
Consortium database, the largest collection of language data of infants who develop autism. Aim 1 of the
proposed study is create a normative model sensitive to the heterogeneity of autistic language development
using summary-level data from the MacArthur-Bates Communicative Development Inventories (CDI). This model
will then be used to predict late talkers. The normative modeling framework quantifies individual differences in
scores, flagging individuals for further follow up. This framework moves away from the limitations of simple “case-
control” designs by allowing for the heterogeneity that is inherent to developmental disorders. We will make our
normative model publicly available, to be used by investigators interested in samples that tend to be smaller in
size, increasing the significance and

Public health relevance
NARRATIVE Predicting Late Talkers in Infants who are at Elevated Familial Likelihood for Autism Twenty-five percent of all siblings of children with autism experience challenges with language development. The proposed study aims to make clinically significant contributions to the prediction of late talkers with two complementary approaches: generating new normative models and using network analyses of lexical profiles. The proposed project would contribute to open science by harmonizing and sharing item-level data from the Communicative Development Inventory.